Development of a Predictive Frailty Clock & Longitudinal Investigation of its Epigenetic Determinants

Project summary/abstract
Longevity studies in mice are expensive and time-consuming, and there are currently no
measures that can predict mortality in a mouse at an earlier time-point. Additionally, there are
very few measures of the overall health of mice that can be assessed longitudinally. In
humans, frailty can predict mortality with greater power than the DNA methylation clock. In my
early postdoctoral work I have validated a mouse frailty index, that increases with age, is
associated with mortality and age-related pathologies, and is sensitive to interventions. In the
Sinclair lab I have used machine learning modelling of this mouse frailty index to make the
Analysis of Frailty in Death (AFRAID) clock that can predict the lifespan of male C57BL/6 mice
aged 21 months or older with accuracy of approximately 1.7 months. We hypothesis that frailty
clocks that include a range of measures including physiological and molecular measures
(blood-based Analysis of Frailty in Death, bAFRAID) will accurately predict lifespan in younger,
female mice and different strains. To test this hypothesis I will use previously collected
longitudinal health and molecular data from C57BL/6 mice, as well as collect lifelong health
data, plus blood and stool samples, from UM-HET3 mice. I will use regression modelling of all
measured outcomes to develop optimized ‘bAFRAID clocks’ that predict time to death in mice
of both strains, and both sexes. For Aim 2, I will test the hypothesis that epigenetic
dysregulation underlies the development of frailty in mice. I will use longitudinal assessments,
and cutting-edge epigenetic tools (including TIMEseq for DNA methylation and CUT&Tag for
histone modifications) to investigate the relationship between epigenetic changes and the
bAFRAID clocks. Completion of this project will provide important tools for the field, and allow
us to understand whether epigenetic changes precede the development of frailty in mice.

Public health relevance
Narrative This project aims to develop a new tool to assess the overall health of a mouse and predict early in a mouse’s life when it will die. This assessment will be an important tool for the aging research field to increase the efficiency of studies looking at interventions to delay aging, and to help us understand the underlying mechanisms of the aging process.